Alteration of skin immune environment by sand fly saliva across progressive Leishmaniasis

Summary
Visceral leishmaniasis (VL), caused by Leishmania donovani complex spp. causes between 20,000-
40,000 deaths a year. L. infantum is the cause of VL in the Mediterranean basin and imported to both South
and North America. L. infantum is zoonotic with canid reservoirs. Leishmania spp. are transmitted primarily
between mammalian hosts by female Lutzomyia or Phlebotomus sand flies. It has been established that both
sand fly and host factors modulate local dermal immunity when and where parasites first encounter skin,
guiding immunity locally and systemically and impacting infection outcomes. Relatively little is known about the
skin immune environment during progressive VL, how dermal immune changes alter host infectiousness or
responses to immunomodulatory sand fly salivary components. Skin parasite burden in dogs with L. infantum
infection correlates with transmission efficiency, more so than parasitemia, though dogs with late-stage
disease were less infectious than those with mild-moderate disease. We have shown that asymptomatic VL
clinical status was associated in dogs, as in humans, with productive Th1 type responses, while symptomatic
infection correlated with presence of exhausted CD4+ and CD8+ T cells, significant expression of Programmed
Death 1 (PD-1) and its ligand, PD-L1 on both B cells and macrophages and loss of macrophage parasite
clearance. These findings collectively lead us to hypothesize that immune cell responses in subclinical or
clinically infected hosts’ skin, whether from dogs or humans, dictate host infectiousness. We will address this
hypothesis through three specific aims in this proposed work, 1) Identify unique dermal immune environments
in subclinical vs. clinical hosts that alter infectiousness to naïve sand flies, 2) Evaluate how the functions of
sand fly salivary proteins are impacted by skin changes during progressive VL leading to new understanding of
vector saliva-host interactions and how they contribute to infectiousness to sand flies and 3) Evaluate how
alteration of the dermal immune environment through dermal immunotherapy alters bite-site inflammation and
transmission. The work proposed here is therefore significant, as it provides infection control relevant
evidence regarding the dermal microenvironment and how it alters infectivity during progressive L infantum
infection. The studies proposed here are significantly innovative as they quantitatively on a spatial level
assess how parasite burden and different dermal inflammatory states alter infectiousness to sand flies. Using
purified salivary antigens, skin biopsy, histopathologic and transcriptome analysis and a key unique natural
infection cohort, we will determine how progressive VL alters the landscape in which vector salivary proteins
operate with consequences for understanding both host infectiousness and the epidemiology of VL. When
completed, findings from these proposed studies will both underscore how progressive dermal inflammation
impacts reservoir host infectiousness and provide critical data to further assess appropriate interventions to
prevent canine-sand fly-human transmission.

Public health relevance
Narrative Visceral Leishmaniasis (VL), caused by Leishmania infantum in the Mediterranean basin and imported from there into both South and North America, continues to be a fatal disease if cases are not detected and treated. Dogs are predominant reservoir hosts for visceralizing Leishmania spp. In this proposed work we will use this critical model system to understand how inflammation from this dermotrophic protozoan alters responses to sand fly saliva and whether it can be treated via immunotherapy.